Altered Lipid Metabolism in Luminal Breast Cancer Stem Cells and Endocrine Resistance

Project Summary/Abstract:
Over two thirds of newly diagnosed breast cancer patients have estrogen receptor (ER) and progesterone
receptor (PR) positive or "luminal" breast cancer. Endocrine therapy is standard of care for these patients and
frequently results in long-term disease-free survival or cure. However, one third of luminal breast cancer patients
experience recurrence with metastatic and therapy-resistant disease. Recurrence is thought to arise from cancer
stem cells (CSCs), a rare subpopulation of cancer cells within a tumor that exhibit stem-like characteristics.
These include quiescence, metabolic flexibility, and resistance to endocrine and chemotherapies. These
subpopulations are difficult to study in luminal breast cancers due to tumor heterogeneity that is not well
understood and, while some tumors contain CD44+ cells, others lack such conventional CSC markers. Our lab
has identified that a subpopulation of cytokeratin 5 (CK5)+ cells within luminal breast cancers contain CSC
properties including resistance to endocrine and chemotherapies, and increased tumorsphere formation and
tumor-initiation relative to CK5− cells. Additionally, we found that the CK5+ subpopulation expands with either
progestin treatment or endocrine therapy such as tamoxifen (Tam) or estrogen withdrawal (EWD). CK5+ cells
lose ER and PR expression and thus endocrine sensitivity. We used CK5 as a marker for luminal breast cancer
CSCs to investigate unique CSC biology and to identify pharmacological targets to prevent disease recurrence
for breast cancer patients. Lipidomic analysis of luminal breast cancer cells under EWD or that are Tam-resistant
(TamR) revealed a significant loss of triglyceride analytes compared to control T47D cells. In addition, EWD and
TamR cells lack visible lipid storage by ORO staining and fail to induce lipid droplet formation with progestins,
as typically observed in PR+ luminal breast cancer cell lines. EWD and TamR T47D cells show decreased
expression of de novo fatty acid synthesis enzymes, FASN and ACC1, compared to control cells suggesting the
lipogenic phenotype typically observed in luminal breast cancer is lost in endocrine resistance. Together, I
hypothesize that endocrine resistant luminal breast cancer cells recycle rather than store lipids and this is
necessary to maintain CSC function. To test this, I plan on defining the mechanism by which endocrine resistant
breast cancer cells shift lipids from storage in Aim 1 and assess the effect of lipid storage on luminal breast CSC
function in Aim 2. Understanding CSC lipid biology in breast cancer endocrine resistance is a critical step in
identifying therapeutic targets for recurrence prevention.

Public health relevance
Project Narrative: Luminal breast cancer patients experience pro-longed risk of recurrence extending past 5-years post tumor resection. Our lab and others have shown that endocrine therapies increase endocrine resistant cancer stem cell (CSC) populations which are hypothesized to drive breast cancer recurrence. The goals of this proposal are to elucidate mechanisms behind CSC lipid remodeling in order to identify novel therapeutic targets that would aid in the treatment and prevention of endocrine resistant breast cancer recurrence.